Studies of Global Signal Transduction

Abstract
Research in my laboratory has centered on the development and application of multi-disciplinary approaches to
study signal transduction pathways important in normal physiology and, when de-regulated, in disease. This
began with our discovery and cloning of a novel signaling partner for the epidermal growth factor receptor, the
human Cdc42 protein, a small GTPase highly conserved from yeast to humans, and continued with the
identification of many Cdc42 regulatory proteins and signaling targets. The conservation of Cdc42 throughout
evolution accounts for the many fundamentally important roles it plays in cell biology and organism development,
including the regulation of cell growth and migration, and the establishment of cellular polarity. We then
discovered an unanticipated but highly significant function of Cdc42 in directing the upregulation of metabolic
activities that generate the necessary building blocks for the biosynthetic processes required for a wide range of
cellular functions. They also provide a mechanism to connect the various intracellular processes regulated by
Cdc42 to the surrounding environment by directing the biogenesis of extracellular vesicles (EVs), which have
now been implicated in mediating intercellular communication across the evolutionary spectrum from bacteria to
higher organisms. Recently, we found that these metabolic activities are mediated through the assembly of large
protein complexes. Understanding how these metabolic/signaling complexes assemble should hold important
clues to their regulatory and catalytic mechanisms, as well as shed light on a long-standing question of how
Cdc42 activates a critically important protein kinase, mTOR (mechanistic Target Of Rapamycin), as a necessary
step for cap-dependent mRNA splicing, the neuronal differentiation of embryonic stem cells (ESCs), and the
survival of cancer cells under stressful conditions. We have also recently discovered important roles for EVs in
a number of biological contexts. Determining the biochemical and structural features of multi-protein signaling
complexes that activate glutamine metabolism and mTOR, essential for the growth and survival of cells, and
moving the exciting field of EVs forward, represent major research efforts for our laboratory in the next 5 years.
We will address key gaps in our knowledge surrounding these broad areas of study by determining how Cdc42
directs the formation of signaling nodes with important functions in cell biology and significant implications for
disease, by defining their unique biochemical characteristics and 3D structures. We also will set out to address
questions representing important next steps for the development of the EV field by defining the biochemical
determinants and signaling cues that dictate the loading of essential EV cargo, and by gaining insights into their
structural features that enable their various biological functions. To achieve these goals, we will leverage our
expertise in signal transduction and benefit from a strong group of collaborators.

Public health relevance
Project Narrative The efforts of my research program have been directed at probing the actions of membrane receptors and their G protein signaling partners that influence cell growth, differentiation, and development. These studies have culminated in a series of exciting new discoveries that describe how these signal transduction pathways are linked to the assembly of multi-protein complexes that regulate the metabolic activities of cells and the biogenesis of extracellular vesicles, important in embryonic stem cell function, differentiation, cellular senescence and aging, and infectious disease. By probing the signaling mechanisms that regulate these metabolic complexes and the biogenesis and function of extracellular vesicles, together with elucidating their structural features, we expect to gain new insights into the critical roles they play in a broad spectrum of biology and disease, as well as highlight new targets and strategies for therapeutic intervention.